Molecular Imaging to Identify Regulators of G-protein Signaling Proteins in Human Neutrophils and Their Role in Vasculitis

Project Summary/Abstract
Anti-neutrophil cytoplasmic antibody (ANCA) vasculitis (AAV) is a systemic autoimmune disease caused by
pathogenic autoantibodies. The disease causes inflammation of small blood vessels in the kidneys,
respiratory tract, and other organs leading to irreversible organ damage. Current immunosuppressive
treatment strategies are often complicated by infections, adverse metabolic effects, infertility, and the
development of malignancies. AAV is marked by a relapsing course in many patients. Unfortunately, there
are currently no tools available to reliably predict the risk of disease relapse or response to treatment in
individual patients.
The Regulators of G Protein Signaling (RGS) are a family of proteins that inhibit the functional responses
of G-protein coupled receptors (GPCR) by accelerating the hydrolysis of GTP to GDP. Alternatively, RGS
proteins are known to regulate non-GPCR proteins, in particular the PI3K/Akt signaling axis. RGS proteins
can interact with the p85 subunit of PI3K to facilitate the activation of Akt, though no study has probed
the role of this interaction in the regulation of neutrophils. Because chemokines, leukotriene B4 (LTB4) and
the activated complement component, C5a, play key roles in the onset and progression of AAV, it is important
to identify and understand molecules and pathways that modulate the responsiveness of neutrophils to these
molecules. Specific Aim 1 will determine the molecular interactions for RGS18 and RGS19 in human
neutrophils. Specific Aim 2 will test the hypothesis that the C5a receptor blocker, Avacopan, blocks C5a-
indued RGS signaling. The knowledge gained may ultimately allow for tailoring of treatment regimens to
disease activity on an individual basis and provide important new insights into the organization of RGS proteins
in neutrophils and new mechanisms that can be targeted to use as therapy in AAV and innate immunity
diseases.

Public health relevance
Project Narrative Neutrophils are the primary effector cells that initiate and amplify tissue damage in vascular diseases including anti-neutrophil cytoplasmic autoantibody (ANCA)-associated vasculitis. Because chemokines, leukotriene B4 (LTB4) and the activated complement component, C5a, play key roles is this process, it is important to identify and understand molecules and pathways that modulate the responsiveness of neutrophils to these molecules. The Regulators of G Protein Signaling (RGS) are a family of proteins that inhibit the functional responses of G- protein coupled receptors (GPCRs) by accelerating the hydrolysis of GTP to GDP. The overall hypothesis is that RGS proteins have the potential to play an important role in modulating neutrophil function in inflammatory kidney diseases.